AD/ADRD Pilot Core

AD/ADRD Focus Pilot Core (Core F) Project Summary
The overarching goal of the Alzheimer's Disease and Alzheimer's Disease Related Dementias (AD/ADRD) Focus
Pilot Core (Core F) is to promote the advancement of science and engineering for predictive analytics, for clinical
decision support, or for the care of adults with AD/ADRD. To advance this mission, we will solicit, fund, and
support pilot projects focused on innovative technologies and AI approaches for several important aspects of
aging in place, and, more specifically, projects that respond to the specific challenges of those with an AD/ADRD
diagnosis. To name a few, we will fund pilots focused on developing AI methods and software for the processing
and integration of data from home monitoring technology with clinical data from EHRs, on analysis of integrated
data using automated machine learning, or on incorporating validated AI models into clinical workflows for
decision support within a health system, in the home, or any other point of care. The core will be led by Dr.
Graciela Gonzalez-Hernandez, Associate Professor of Informatics and Senior Faculty of the Institute of
Biomedical Informatics (IBI) at the University of Pennsylvania, and Director of the Health Language Processing
(HLP) Center within the institute. With over 100 publications in prestigious journals and conferences, Dr
Gonzalez-Hernandez’s 19 years of academic career plus 5 more in industry bring a unique perspective with
respect to the integration of research and applicable software systems, and their adequate construction and
distribution. She was Director of the Database Management and Biostatistics Core for the NIH-funded Arizona
Alzheimer’s Disease Center for 8 years (2008 to 2016), where she helped organize the annual selection of Pilot
Projects. She is a member of the NLM Board of Scientific Advisors (effective as of the Spring of 2021) and of the
NIH Biodata Management and Analysis (BDMA) study section since 2019. She was previously a member of the
NIH/NLM BLIRC study section (2009-2013). Overall, in line with the overarching theme of the PennAITech
Collaborative, Core F seeks to provide comprehensive, integrated, and continuous support and promotion of
Pilot projects that connect novel technologies for monitoring aging adults in the home with research activities
and clinical care, specifically aimed at addressing the acute needs of the AD/ADRD patients and their caregivers
and the specific nuances and progression of AD/ADRD. To our knowledge, a comprehensive pipeline from home
to clinic and back that addresses the many challenges of AD/ADRD does not yet exist. Building and extending
this pipeline will be central to our pilot funding program. The AD/ADRD Pilot Core has the following Specific
Aims: (1) to solicit, review, and support pilot studies that develop or advance the use of AI and technology for
AD/ADRD predictive analytics, clinical decision support, or the care of adults with AD/ADRD, (2) to foster
collaborations among affiliated Penn investigators, our network of peer institutions and research centers, and
pilot program researchers, and (3) to provide high quality informatics, computational, and product design and
development support, education, and training for researchers, pilot project applicants, and collaborators.

Public health relevance
AD/ADRD Focus Pilot Core (Core F) Project Narrative The overarching goal of the Alzheimer's Disease and Alzheimer's Disease Related Dementias (AD/ADRD) Focus Pilot Core (Core F) is to promote the advancement of science for predictive analytics, for clinical decision support, or for the care of adults with AD/ADRD. Led by Dr. Graciela Gonzalez-Hernandez, Associate Professor of Informatics and Senior Faculty of the Institute of Biomedical Informatics (IBI) at the University of Pennsylvania, and Director of the Health Language Processing (HLP) Center, Core F seeks to provide comprehensive, integrated, and continuous support and promotion of Pilot projects that connect novel technologies for monitoring aging adults in the home with research activities and clinical care, specifically aimed at addressing the acute needs of the AD/ADRD patients and their caregivers and the specific nuances and progression of AD/ADRD. To our knowledge, a comprehensive pipeline from home to clinic and back that addresses the many challenges of AD/ADRD does not yet exist and building and extending this pipeline will be central to our pilot funding program.